CCTN-CORE FUNCTION ACTIVITIES - SITE OF MALE CONTRACEPTIVE STUDIES - UWASH

The Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD) has a mission to develop safe and effective contraceptives for women and men. The mission of the Contraceptive Clinical Trials Network (CCTN) is to develop protocols and conduct clinical trials that will assist in product development with the end goal to provide effective and safe contraception for women and men.